Biorepository Shared Resource

BIOREPOSITORY SHARED RESOURCE (BRSR)
PROJECT SUMMARY/ABSTRACT
The Biorepository Shared Resource (BRSR) provides well-characterized, high-quality, de-identified specimens
with annotated data for clinical and basic science cancer research purposes for members of the UC Davis
Comprehensive Cancer Center (UCDCCC). Accredited by the College of American Pathologists (CAP), the
BRSR focuses on quality, accuracy, and procedural consistency of biospecimen management upon which
research outcomes directly depend. The BRSR functions as a centralized tissue bank to provide UCDCCC
members and other researchers access to cancer and non-cancer-related specimens (fresh/frozen tissue,
paraffin blocks/sections and fluids), procured and stored using international standards of best practices and
protocols compliant with the Office for Human Research Protection. In addition, BRSR supports all clinical trials
and other projects such as the U54 University of California Minority Cancer PDX (UCaMP) project, as well as
tissue collection and storage for PDX models. The BRSR is centrally located at UCD Health (UCDH) with an
office and lab on the second floor of the main hospital, and at the histology lab in the nearby Pathology
building. Oversight and management of the BRSR is provided by the Director, Regina Gandour-Edwards,
MD, a clinical pathologist with over 30 years of experience as a surgical pathologist and translational
researcher; and the manager, Irmgard Feldman, a certified clinical research professional with more than 12
years of experience in specimen collection, processing, biobanking and management. The Specific Aims for
the BRSR are to 1) Procure, prepare, store and disperse malignant, benign and normal human biospecimens
from a centralized biorepository that are collected using standardized procedures and continuously audited
quality management programs. 2) Provide high quality pathological and clinical annotated data using a secure
and interactive on-line database system (OpenSpecimen). 3) Ensure compliance with all mandated regulatory
processes (HHS, IRB, HIPAA, SRC) thereby promoting ethical research by UCDCCC members and other
researchers. 4) Provide experienced pathologic consultation to investigators using human specimens for
scientific correlation. 5) Efficiently prioritize, track, and disperse biospecimen requests via a rapid and
standardized, web-based approval and monitoring process. 6) Provide Tissue Microarray (TMA) construction
and histology services for UCDCCC investigators and their collaborators.